The VA Eosinophilic Esophagitis Million Veteran Program (VA EoE-MVP) Cohort for Clinical, Environmental, and Genetic Epidemiology

Eosinophilic esophagitis (EoE) is a chronic allergen/immune-mediated disease of the esophagus affecting
approximately 1 out of every 2,500 persons. EoE incidence and prevalence are dramatically rising in the
United States (US) and globally, and it is unclear what triggers or factors are contributing to these trends.
Previous epidemiologic studies of EoE have been challenged by small sample sizes and, therefore, the ability
to robustly measure and evaluate specific clinical, environmental, and genetic etiologic factors associated with
EoE development and disease progression. Large, validated cohort studies with access to environmental data
that can be analyzed in conjunction with genomic and clinical data, such as comorbid information,
pharmacologic data, procedure and histology reports, and other outcomes data, are critical to address EoE
epidemiology knowledge gaps and advance science and discovery in EoE. The Veterans Health Administration
(VHA) data infrastructure is the ideal system to study the epidemiology and genetic underpinnings of EoE as it
contains robust databases, namely the Corporate Data Warehouse (CDW) and the Million Veteran Program
(MVP), which comprise clinical, environmental, and genetic information for thousands of Veterans with a
diagnosis of EoE. VHA data have been leveraged to create one of the largest [and diverse] research cohorts of
individuals with EoE (n=6,637), termed the VA eosinophilic esophagitis cohort (VA E-O-ECHO). Use of this
cohort is proposed to perform observational studies and identify risk factors associated with EoE diagnosis and
disease outcomes. Furthermore, this cohort creation strategy will be extended to develop a validated research
cohort using VA MVP data, the EoE-MVP cohort. Case-control genome-wide association studies (GWASs) will
be performed using the EoE-MVP cohort to identify significant risk loci associated with EoE diagnosis and
severe disease phenotypes. Structured environmental survey responses from the EoE-MVP cohort will be
used to investigate deployment and line-of-duty environmental exposures associated with EoE. The
overarching goal of this research proposal is to organize structured and unstructured big data within the CDW
and MVP to evaluate risk factors for EoE and EoE disease outcomes, and ultimately improve the
understanding of [EoE pathogenesis and natural history to improve clinical care.] The specific aims for this
project are to: (1) Identify clinical and environmental factors associated with EoE. Associations between
clinical/environmental factors and EoE diagnosis will be examined using usual healthcare data (CDW) and
drawing from detailed MVP surveys, utilizing a large sample case-control design. (2) Identify genetic factors
associated with EoE diagnosis using the MVP. MVP genomic data will be leveraged to conduct GWASs
and GWAS meta-analyses for EoE. Genetic architecture of EoE will be characterized by performing genetic
correlations studies using associated atopic conditions such as asthma and atopic dermatitis. Genetically
correlated phenotypes will be used to perform multi-trait analysis of GWAS and boost statistical power for risk
loci discovery for EoE. Lastly, gene set enrichment analyses will be performed to study biological
processes/pathways underlying EoE. [(3) Identify clinical, environmental, and genetic factors associated
with EoE treatment response and other outcomes. Disease natural history of every individual with EoE in
the MVP will be mapped using robust clinical data, including objective endoscopic and histologic findings.
Associations between clinical, environmental, and genetic factors and EoE outcomes will be examined using
case-control studies. Fundamentally, this work will serve as a hypothesis-generating launchpad for the
principal investigator and others to advance science and clinical management in EoE and improve health and
well-being for individuals with EoE. For example, we anticipate establishing prospective randomized control
trials with results from this CDA to explore therapeutic efficacy in the setting of individualized risk factors and
help inform a patient-centered care paradigm for EoE.]

Public health relevance
[Eosinophilic esophagitis (EoE) is disqualifying for appointment, enrollment, and retention into military service. EoE incidence is rising among active component service members of the Army, Navy, Air Force, and Marine Corps as well as Veterans.] EoE is a life-long, comorbid condition that causes inflammation of the esophagus. EoE can progress to narrowing of the esophagus, which may result in significant trouble swallowing and, in the most severe cases, food impactions within the esophagus requiring emergent removal of the food item. Annual costs of EoE care in the United States exceed $503 million. While EoE can affect people of all ages, it disproportionately affects males compared to females. Active-duty members and Veterans are a high-risk population for developing EoE based on demographics alone, but also potentially due to environmental exposures experienced during service or deployment. It is critical to study EoE risk factors in the Veteran population to understand this disease and improve health and well-being.